Electron Transfer in Iron and Copper Oxygenases and Oxidases

PROJECT SUMMARY/ABSTRACT
Oxygenase and oxidase enzymes must coordinate the delivery of four protons and four electrons to
O2 in order to prevent the formation of harmful, partially reduced reactive oxygen species. The risks posed
by reactive intermediates are so great that aerobic organisms need mechanisms to protect oxygen-
utilizing enzymes from inactivation when primary electron/proton transfer mechanisms are disrupted.
Radical transfer pathways that deliver strongly oxidizing holes from frustrated reactive intermediates in
enzyme active sites to the protein surface for reaction with intracellular antioxidants can provide such
protection. These radical transfer pathways are likely constructed from chains of Trp, Tyr, Cys, and
possibly Met residues. This research program will focus on the cytochromes P450 (P450), the 2-oxo-
glutarate dependent nonheme iron oxygenases (2OG-Fe), and the multicopper oxidases (MCOs).
The cytochromes P450 are members of a superfamily of heme oxygenases involved in xenobiotic
metabolic and biosynthetic pathways. In mammals these functions include drug metabolism, conversion
of lipophilic molecules to more polar products for enhanced elimination, steroid biosynthesis, and
eicosanoid synthesis and degradation. Cytochromes P450 also are responsible for 66% of enzymatic
activation of carcinogens. Elucidating the mechanisms by which P450s avoid inactivation in the presence
of diverse substrates can contribute to defining therapeutic drug efficacies and mitigating the risks of
adverse drug-drug interactions. Drugs for cancer treatment and prevention have been designed to target
P450s through competitive inhibition and mechanism based irreversible inhibition. To understand the
biological response of P450s to these compounds, it is essential to delineate the mechanisms that the
enzymes use to protect themselves against degradation.
Enzymes from the 2OG-Fe superfamily use 2-oxoglutarate as a 2-electron donating co-substrate,
Fe2+ as a cofactor, and O2 to effect the hydroxylation of organic substrates. The 60-70 human 2OG-Fe
enzymes exhibit a wide array of biological functions including collagen biosynthesis, lysyl hydroxylation
of RNA splicing proteins, DNA repair, RNA modification, chromatin regulation, epidermal growth factor-
like domain modification, hypoxia sensing, and fatty acid metabolism. Enzymatic turnover also is
accompanied in some cases by generation of reactive oxygen species. Elucidation of ROS generating
pathways will provide deeper insight into the functioning and mis-functioning of these enzymes.
The blood and intestinal human enzymes ceruloplasmin and hephaestin are MCOs involved in iron
oxidation. Oxygen reduction occurs at a trinuclear copper center (TNC) and a fourth electron is provided
by a distant type 1 copper center. A Trp or Trp/Tyr adjacent to the active site may transiently provide the
fourth electron. The proposed studies will elucidate the role of the TNC proximal Trp/Tyr residues.

Public health relevance
PROJECT NARRATIVE Aerobic organisms utilize the oxidizing power of molecular oxygen but must avoid the harmful effects of partially reduced oxygen species. Organisms that utilize oxygen have developed mechanisms to protect oxygenases and oxidases from damage in the event of unsuccessful substrate reactions. Pathways composed of tryptophan and tyrosine residues provide that protection by guiding potentially damaging oxidants to enzyme surfaces for reaction with external reductants.